NMR-based dynamic assessment of TCR transmembrane conformational states linked to T cell function

ABSTRACT
The DETCR is a surface membrane complex consisting of the ligand-binding clonotypic DE heterodimer in non-
covalent association with the dimeric CD3 signaling subunits (CD3HJ, CD3HG and CD3]]) whose sensitivity and
specificity are critical for protective host immunity. DE TCRs have been shown to manifest an unusual, dynamic
and force-responsive mechanical regulation of pMHC ligand binding. Moreover, force induces different receptor
conformers associated with energized and non-energized TCRDE ectodomain states. To focus on how
information on TCR ligand occupancy is transduced into the cell, we have begun to study the TCRD
transmembrane and cytoplasmic domain (TMC) structure. Unexpectedly, we observed that this domain forms a
bipartite helix segmented by a dynamic hinge. The first transmembrane (TM) helix contains its two charged
residues, R251 and K256, pointing outward from opposite sides with the latter controlling TM depth and all CD3
dimer associations. Mechanotransduction-mediated triggering of early T cell activation is modulated by these
residues and, conversely, their disposition may be altered when physical force load is applied to the TCRDE-
pMHC bond. Thus, rather than a robust static set of TM interactions, this DETCR dissociative mechanism implies
the presence of dynamic structural conversions between and within segments. Here we shall exploit the latest
advances in NMR direct detection techniques and relaxation and chemical exchange (Rex, CEST, etc.) along
with EPR to directly observe states of individual and assembled components in membrane mimetics, their
distributions and structures. The biological relevance of these structural observations shall be assessed through
mutagenesis that restricts subunits to defined conformations or abrogates intersubunit interactions. Modified
subunits that are assembled into cell surface DETCR complexes will be assessed for impact on pMHC-stimulated
Ca2+ flux, IL-2 production and transcriptomes in T cells. In Aim 1, we shall measure the dynamic behavior of
the TCRDTMC alone or in complex with TCRE, CD3] and CD3G TM segments. TCRDTMC variants whose hinge
is modified to lock in a bent or straightened configuration shall be compared along with that of pTD whose
structure, predicted to be a straightened continuous helix responsible for high basal level activation in early DN3
thymocytes, shall be determined. The potential for TCRDTM K256 to be post-translationally modified during
mechanotransduction by a methytransferase or other enzyme localized to the inner plasma membrane leaflet
shall be assessed. In Aim 2, similar studies will be performed with TCRE and CD3G alone or associated with
other DETCR complex TM components. With respect to CD3G, structural and dynamic changes in both TM and
cytoplasmic tail consequent to ITAM Tyr phosphorylation shall be defined. Given that the majority of medicinal
compounds bind transmembrane segments of proteins, information gleaned herein shall be both of practical and
fundamental significance to target resting or activated conformations.

Public health relevance
Narrative The TCR mediates antigen-specific T cell stimulation important in protection against infections and cancers as well as autoimmune diseases. Insight from this proposal will contribute to TCR knowledge, with relevance for discovery of small molecule drugs and optimal adoptive T cell immunotherapies to control T cell activation.